Establishing a Nationwide Diabetes Surveillance System for Youth and Young Adults: Incidence, Prevalence, Risk Factors, Disparities, and Social Determinants of Health

Project Summary
Alarming increases in both type 1 and type 2 diabetes have been observed among youth in the United States
over the past decade. There is an urgent need for a comprehensive surveillance system to monitor the
prevalence, incidence, and complications of diabetes among youth and young adults, while evaluating
disparities and contributing factors. However, national surveys lack sufficient data on youth and young adults to
support rigorous diabetes surveillance.
The recent development of the EPIC COSMOS database—which includes EHR records from over 289 million
unique individuals, encompassing more than 60% of U.S. residents across all 50 states—offers an
unprecedented opportunity to build a nationwide young-onset diabetes surveillance system. The rich data
elements within COSMOS—including demographics, biomarkers, diagnoses, prescriptions, and social
determinants of health—allow for accurate identification of diabetes cases and examine disparities in risk
factors, complications, and medication use in diabetes. Given our strong experience as a leading user of the
COSMOS network, we propose to develop a nationwide diabetes surveillance system based on this database,
in response to CASSIDY’s RFA (Component A). The detailed aims are as follows:
Aim 1: Refine the DiCAYA CP algorithms for automated identification of prevalent and incident cases
of type 1 and type 2 diabetes among youth and young adults.
Aim 2: Estimate the prevalence and incidence of type 1 and type 2 diabetes.
Aim 3: Assess the risk factors for diabetes complications, the onset of acute and chronic
complications, and the use of diabetes medications among youth and young adults with
diabetes.
Dissemination: We will work closely with the CDC and coordinating center to (1) adopt a CDM for data analysis
and sharing across centers, and (2) disseminate study results through EPIC stakeholders and nationally by
contributing to the CDC’s National Diabetes Statistical Report and high-impact scientific publications.

Public health relevance
PROJECT NARRATIVE This project aims to establish a nationwide, real-time diabetes surveillance system using EPIC COSMOS, the largest EHR database in the U.S., to monitor the prevalence and incidence of diabetes among youth and young adults. Leveraging advanced data analytics, innovative algorithms for diabetes identification and classification, and geospatial analyses, this study will provide critical insights into trends, disparities, and risk factors associated with diabetes and its complications in this population. The findings will inform precision public health policies and targeted interventions to reduce the diabetes burden and associated disparities across the U.S.